Identifying the Determinants of Immunoediting During Glioblastoma Immunotherapy

Project Summary:
The most common primary malignant brain tumor, glioblastoma (GBM) remains uniformly fatal despite standard
therapy including surgical resection, radiation, and chemotherapy. Immunotherapy, such as immune checkpoint
blockade (ICB), has transformed standard of care across multiple solid tumors but has yet to demonstrate treatment
efficacy in phase III trials for GBM. Reasons for immunotherapy resistance in GBM include its immunosuppressive
tumor microenvironment (TME) and marked intra-tumoral heterogeneity. Indeed, recent studies have elucidated
GBM malignant cellular heterogeneity by defining four highly plastic tumor cell states. Patients harboring a
predominantly mesenchymal (MES)-like tumor state have the worst prognosis to standard therapy, with non-MES-
like GBM tending to shift to the MES-like state at recurrence, reflecting treatment resistance. However, MES-like
GBM has also been shown to have high HLA class I and II expression, features that are predictive of ICB response
in other tumor types. Supporting the notion that MES-like GBM is particularly immunogenic, I have shown in
preliminary work that, despite the opposite for standard therapy, MES-like GBM demonstrates improved survival
to anti-PD-1 blockade, with patients shifting away from the MES-like state at recurrence. Moreover, although GBM
responders to ICB have been shown to undergo neoantigen immunoediting during treatment, my preliminary data
reveal that neoantigen burden is not associated with ICB response. This suggests that other tumor features
besides neoantigen availability, such as tumor cell state, dictate neoantigen-directed tumor eradication in
GBM. The overarching goal of this work is to identify the determinants of immunoediting during immunotherapy for
GBM, and to elucidate whether and by what mechanisms immunotherapeutic modality shapes mechanisms of
immunotherapy resistance. I hypothesize that while neoantigen immunoediting during anti-PD-1 monotherapy
occurs predominantly of MES-like GBM cells, personalized neoantigen vaccination (‘NeoVax’) enables neoantigen
immunoediting agnostic of tumor cell state by upregulating HLA in non-MES-like tumor cells, via IFNγ from
NeoVax-induced T cells. Aim 1 will characterize the cell state and TME of tumor cells undergoing neoantigen
immunoediting in a cohort of anti-PD-1 treated GBM patients. Bulk genomic analyses will be integrated with a novel
single-nucleus spatial transcriptomic approach, Slide-GoTags, that concurrently enables targeted genotyping of
neoantigens and TCR-sequencing. Aim 2 will elucidate the mechanisms by which NeoVax enables immunoediting
of non-MES-like tumor cells during anti-PD-1 therapy, using patient samples from an ongoing clinical trial. This will
entail Slide-GoTags, ex vivo assays for measuring and identifying vaccine-specific T cell clonotypes, and co-
cultures involving patient-derived gliomaspheres and CRISPR-edited T cells. Elucidating the mechanistic
determinants governing tumor eradication and immune escape during GBM immunotherapy has the potential to
improve GBM clinical outcomes by guiding the development of future immunotherapeutic strategies.

Public health relevance
Project Narrative: Cancer immunotherapies such as immune checkpoint blockade (ICB) have enabled improved clinical outcomes across many solid tumors, but have yet to demonstrate efficacy in glioblastoma—the most common and aggressive primary brain tumor. This proposal seeks to identify the tumor features that enable immune-mediated tumor eradication in GBM patients receiving ICB, the mechanisms by which combining ICB with personalized cancer vaccination promotes such features, and the remaining barriers to achieving durable tumor control. Elucidating such mechanisms of immunotherapy response and resistance may guide future therapeutic strategies that achieve improved clinical outcomes for GBM patients.